Investigating the contributions and impact of neutrophil activity in a comorbid model of AD and VCID

Project Summary/Abstract
Alzheimer’s disease (AD) is the most common form of dementia often presenting with vascular
contributions to cognitive impairment and dementia (VCID). Growing evidence has highlighted pathological
contributions from an immune cell within the peripheral immune system: neutrophils. In cases of
hyperhomocysteinemia (HHcy), a common risk factor for VCID, neutrophils cause vascular damage by
oxidative stress and releasing products for matrix degradation as well as increasing blood hypercoagulability
via release of neutrophil extracellular traps (NETs), any of which can be a confounding factor in current
therapeutics. This proposal aims to investigate the mechanisms by which neutrophils are contributing to
worsened cerebrovascular outcomes in AD and VCID, and the impact of depleting neutrophils on disease
pathology to give a broader picture of immune-mediated neuropathologies.
To answer these questions, we propose to examine the neutrophil response to APP, VCID, and APP-VCID
comorbidities (Aim 1) and determine whether chronic depletion of neutrophils reduces neuropathology for each
case (Aim 2). We hypothesize that mechanisms unique to each pathology will be additive while overlapping
mechanisms across pathologies will be exacerbated. For Aim 1, cohorts of wild-type or Tg2576 mice will be
placed on control diet or diet to induce HHcy. In vivo multiphoton microscopy imaging, flow cytometry, single-
cell RNA sequencing, and intravascular labeling of leukocytes prior to tissue collection will be used to examine
upregulated mechanisms. In Aim 2, mice from Aim 1 will be given isotype control antibody or murinized anti-
Ly6G antibody for chronic neutrophil depletion at the start of diet to assess changes in physiological and
cognitive outcomes. We will test the hypothesis that chronic depletion reduces the severity of comorbid
disease pathology by longitudinal imaging using MRI, multiphoton imaging, and immunohistochemical assays
for neuroinflammation and vascular damage. These aims will provide important information on an overlooked
factor to vascular dementias.
Achievement of these aims will aid in my own goals of becoming an independent researcher by improving
my scientific knowledge of VCID and AD as well as supplement my available research skills in MRI,
immunohistochemistry, and single-cell transcriptomics. To complete these aims, I have the resources at
Indiana University – Indianapolis such as the Alzheimer’s Disease Research Center as part of the NIH, a
program for developing new mouse models (MODEL-AD) to be used for investigating new treatments (TREAT-
AD), as well as a well-equipped environment for dementia-related studies. My mentor, Dr. Wilcock, and
mentoring committee will guide my professional development by providing assistance with my written and
communicative skillsets as well as expanding upon my academic network. Overall, this proposal will provide
both scientific and professional development training while adding important knowledge to the AD/VCID field.

Public health relevance
Project Narrative Patients with Alzheimer’s disease often present with comorbidities, such as vascular contributions to cognitive impairment (VCID), which is often overlooked in clinical diagnosis. Growing evidence suggests that neutrophils, from the peripheral innate immune system, may play a role in vascular pathologies, for which the inflammatory response by these cells may be worsened by additional comorbidities. This proposal aims to investigate the neutrophil mechanisms contributing to vascular damage and the long-term impact of targeting these cells with the goal of identifying additional therapeutic targets for treatment of AD and related dementias.